Role of GlcSph in cognitive deficits in Lewy body dementias

Parkinson’s disease dementia (PDD) and Dementia with Lewy bodies (DLB) are two neurodegenerative
diseases characterized by cognitive impairments that include executive dysfunction, visual-spatial processing
difficulties and impaired working memory. Cognitive impairments are among the most debilitating symptoms of
these diseases, often leading to institutionalization and severe decline in health. In PD, cognitive symptoms are
often present at diagnosis, but can appear over the course of the disease. In DLB, cognitive changes appear
first followed by the development of motor parkinsonism. Both diseases, collectively termed Lewy body
dementias, are pathologically characterized by aggregates containing the protein α-synuclein, called Lewy
pathology. Lewy pathology is found in brain areas important for cognition including the cortex and
hippocampus where it correlates with cognitive decline. Genetic variations in the gene, GBA1, also associate
with LBDs. GBA1 encodes for glucocerebrosidase an enzyme that metabolizes glucosylceramide. Mutations in
glucocerebrosidase reduce its enzyme activity. Up to 12% of PD cases involved genetic variations in GBA1.
The GBA1L444P mutation, which represents about 35% of all PD-GBA1 mutations, increases risk of cognitive
decline in PD by 5X. We have found that mice heterozygous for GBA1L444P show impaired performance in
behavioral tasks of hippocampal function, and reduced synaptic markers in the hippocampus but not other
brain regions. In addition, GBA1L444P heterozygous mice injected with pre-formed α-synuclein fibrils to induce
formation of inclusions from endogenous α-synuclein, show more abundant inclusions in the hippocampus
compared to wild type mice. In addition, we and others have found that the lipid, glucosylsphingosine but not
glucosylceramide is increased in GBA1L444P heterozygous mice, suggesting this lipid causes pathology and
should be the target of PD-GBA1 therapies. The combined impact of increased GlcSph and enhanced α-syn
aggregation in the hippocampus could be a mechanism by which cognition is impaired in LBDs, which will be
explored in this proposal. First, we will determine if glucosylsphingosine is elevated in brain tissue from
individuals with PD-GBA1 and controls. We will also utilize a model of human α-synuclein aggregation to
determine if pathologic α-synuclein causes changes in glycosphingolipid metabolism in hippocampal and
cortical brain regions. Because reduced glucocerebrosidase has been shown to impair lysosome function, we
will use primary hippocampal neurons to determine if glucosylsphingosine impairs lysosome activity, leading to
a build-up of abnormal α-synuclein. Finally, we will use independent methods to reduce GlcSph in GBA1
L444P heterozygous and wild type mice with and without α-synuclein pathology to determine if decreasing this
lipid prevents defects in hippocampal physiology and related behaviors. Overall, this project will help determine
mechanisms by which GBA1L444P contributes to cognitive decline and help identify therapeutic strategies to
prevent development of cognitive symptoms.

Public health relevance
PROJECT NARRATIVE Both α-synuclein aggregates in the brain and mutations in the gene GBA1 associate with cognitive decline in Parkinson’s disease and Dementia with Lewy bodies. The goal of this project is the determine if the lipid, glucosylsphingosine, plays a role in toxicity caused by pathologic α-syn and mutant GBA1. We will accomplish this using mouse models of mutant GBA1 and α-synuclein aggregations along with analysis of glucosylsphingosine in cortex and limbic regions from human PD-GBA1 patients.